Research Training in Nephrology

DESCRIPTION (provided by applicant): This proposal requests support for the continuation of a research training program in academic nephrology, now under the directorship of Dr. Martin Pollak, Chief, Nephrology Division, Beth Israel Deaconess Medical Center (BIDMC) and Professor of Medicine, Harvard Medical School (HMS). Continued support is requested for six trainees who will spend at least two years in the training program. Most candidates will have received the MD degree or the MD-PhD degree prior to entry but prospective trainees with a PhD and a background in a relevant scientific discipline are also considered. The major criterion for selection is evidence of an interest, ability and commitment for a career in investigative nephrology. Research activities span basic and translational investigations. Current research areas include acute renal failure, mechanisms of cell injury and cell metabolism, ion transport and water excretion, cellular transduction mechanisms, mechanisms of muscle wasting and intracellular protein breakdown, preeclampsia, glomerular pathology, genetics of kidney disease, cellular and transplant immunology, gene regulation, genomics and proteomics of the kidney, angiogenesis, vascular leak, diabetic nephropathy, metabolism, and renal bone disease. The chief method of instruction is intensive personal involvement in a research program under the close supervision of an experienced mentor. Participation in a structured program of career mentoring, research seminars, journal clubs, and laboratory presentations is mandatory for all trainees. The primary facility for training is the Nephrology Division at BIDMC, with additional training sites in the Transplant, Rheumatology, and Interdisciplinary Medicine and Biotechnology Divisions at BIDMC, at Children's Hospital Boston, the Dept. of Medicine (Renal Division) at Brigham and Women's Hospital, and the adult and pediatric Renal Units at Massachusetts General Hospital. A variety of core facilities (animal, genetics, imaging, biochemical, etc.) are available at BIDMC and/or Harvard Medical School, the Harvard CTSA, and at the other training sites. These sites are close to each other, facilitating interactions.

Public health relevance
PUBLIC HEALTH RELEVANCE: There is a well-recognized growing need to educate physician and PhD scientists for research careers in nephrology. Public health will benefit from the significant advances in medicine that can be made by those who have spent several years in a mentored laboratory environment and have learned to apply a range of approaches used in modern biomedical science. This program offers a rigorous training experience to physicians not previously trained in research and to those with PhD degrees who wish to obtain postdoctoral training in kidney-related science. The increasing societal burden of kidney diseases, coupled with a continued nationwide difficulty in attracting physician- scientists to internal medicine in general, and to nephrology in particular, reinforces the public health importance of this program.